Organic Synthesis

ABSTRACT
MSK is committed to the discovery and development of new tools and therapeutic agents for cancer detection,
prevention, and treatment. The major goal of the Organic Synthesis Core is to provide chemical synthesis
services to Center members through a state-of-the art facility staffed by expert professional personnel in
chemical synthesis. The Core operates at the interface of chemistry, biology, and medicine, and has the
capability of supporting medicinal chemistry efforts to produce and evolve lead candidates and tool
compounds in support of Center investigators. The work of the Core has greatly facilitated preclinical studies
at the Center. The Core synthesizes novel molecules that are not readily available, by either following
described procedures, or by developing new and more suitable methods of synthesis.